Consequences of Substance Use on the Development of Impulse Control

Project Summary/Abstract The parent grant is a longitudinal study designed to elucidate mechanisms driving the initiation and progression of substance use is consistent with NIDA and NIMH's recently outlined strategic plans (NIDA, 2016; NIH CRAN, 2015; NIMH, 2015) prioritizing research on the period between adolescence and young adulthood. Defining features of typical adolescent development are increases in sensation seeking followed by more gradual increases in impulse control (described by the Dual Systems model). The discrepancy between developing sensation seeking and impulse control are theorized to result in risk-taking behaviors like substance use. In at-risk youth, these developmental processes may be further discrepant, which may be one mechanism for increased rates and severity of substance use involvement. This renewal project has been documenting the relationship of sensation seeking and impulse control since before substance use onset (10 to 12 years old at study entry), and this renewal will continue to assess these processes and outcomes into young adulthood. More specifically, we continue longitudinal assessments (every 6 months) of our at-risk (due to family history of substance use disorder) and control youth to monitor changes in substance use, impulse control, environmental, sensation seeking, risk and resiliency factors. Outcomes are interpreted from the perspective of the Dual Systems model, and importantly, this work will extend this model by testing: (1) whether impulse control and sensation seeking develop independently from one another; (2) whether impulse control and sensation seeking development has additive or interactive effects on substance use involvement; (3) how the onset and escalation of substance use affects subsequent development of impulse control and sensation seeking; (4) how processes identified in the Dual Systems model develop among adolescents and young adults with family history risk; and (5) how social and environmental factors influence risk and resiliency for substance use and are interpreted in the context of the Dual Systems model. Interpreting these findings within the context of the Dual Systems model will help to refine and extend the key premises of this model, as well as reveal more detail about developmental mechanisms of substance use involvement. As a part of this project, we offer a training opportunity for the 2021 NIDA Summer Research Internship Program. We will provide participants in this internship program with training in (1) clinical research in substance use; (2) assessment of substance use including advanced assessment tools using biosensors as well as conventional paper-based assessment; (3) data entry and management; and (4) academic writing and presentations on the topic of substance use disorder.

Public health relevance
PROJECT NARRATIVE The parent study will advance our understanding of how the development of impulse control and environmental influences, occurring between pre-adolescence through early adulthood, interact with one another to lead to problems with substance use. Understanding these relationships will aid in the identification of the antecedents and consequences of substance use on key processes of development. Identifying factors related to both resiliency and risk will lead to better prevention programs and substance use treatments, which are dependent on a gaining a better understanding of these complex relationships. This NIDA Summer Research Intern(s) project is designed to train an undergraduate student (Celia Allred) develop skills and knowledge in clinical research of substance use. Specifically, our training plan providers experience inn data collection, data management, data analysis, and academic writing/presentations on the topic of substance use disorder.